Alcohol Research in the Science/Practitioner Model

Project Summary/Abstract
This is a competitive renewal of an alcohol research training program (T32) currently in its 19th year that aims to
continue an exceptional track record of training pre and postdoctoral trainees interested in alcohol research
across the lifespan. It supports four predoctoral and four postdoctoral trainees per year, each appointed for two
years. This joint endeavor of San Diego State University (SDSU) and the University of California San Diego
(UCSD) is led by Dr. Edward Riley (Program Director, SDSU) and Dr. Andrea Spadoni (Program Director,
UCSD). The faculty consists of researchers affiliated with the SDSU/UCSD Joint Doctoral Program (JDP) in
Clinical Psychology. The JDP provides a unique opportunity for the training of doctoral students in the
Science/Practitioner model and is consistently ranked as one of the top clinical psychology doctoral programs in
the U.S. The model is guided by the conviction that a solid foundation in the science of psychology is essential
for the modern clinical psychologist. Further, a rigorous scientific core, including the commitment to empirically-
based knowledge and the development of research skills, is regarded as fundamental in educating clinical
psychologists. Finally, this model is consistent with the NIH goal of translating research to the clinic. The
environment for this training is rich with resources, skilled mentors, ample research funding, and an extremely
collegial atmosphere that encourages collaborative studies between labs and universities. The T32 prepares
trainees for successful careers in research and academic environments with intensive mentored and specialized
training experiences in research addressing the determinants and consequences of alcoholism. Hands-on,
mentored alcohol research experience, in conjunction with workshops and seminars in addictions, research
methodologies, responsible conduct of research, data science, enhancing reproducibility, manuscript/grant
writing, and career development are the key activities of this training program. Research experiences encompass
a broad range of alcohol-related areas such as neural risk factors and consequences of alcohol exposure, fetal
alcohol spectrum disorders, adolescent substance use, and comorbidities. While pre- and postdoctoral trainees
alike receive extensive training in the behavioral sciences and in alcohol and other substance use and related
disorders, postdoctoral training is highly tailored toward the achievement of individual career goals. Since its
inception in 2002, this training program has undergone constant refinement and it will continue to do so to meet
the needs of the trainees and the evolving addictions research field. Its graduates continue their success in
primarily academic/research settings. Their achievements and feedback about their experience indicate that they
acquire the skills and scientific discipline necessary to be successful researchers and that they have the clinical
skills to apply their knowledge and ask relevant questions regarding alcohol and other substance use disorders.

Public health relevance
Project Narrative Alcohol use and related disorders are a global public health issue. According to the World Health Organization (WHO), alcohol consumption ranks as a leading risk factor for disease burden and in 2016, alcohol use resulted in 7.2% of all premature deaths, with young people being disproportionately affected. Specialized training is required to tackle this immense problem, particularly as it relates to clinical research. This proposal focuses on providing this training to pre- and postdoctoral fellows working with faculty at San Diego State University and the University of California San Diego.